Nanobody-mediated proteolysis of Aspergillus fumigatus transcription factors in vitro and in vivo

Aspergillus fumigatus (Afu) is the primary human filamentous fungal pathogen and has been
designated by the World Health Organization as one of the four most critical fungal pathogens
impacting humans. The patient population at risk to Afu infections continues to rise owing to
increased utilization of immune suppression for organ transplants, viral infections and cancer
chemotherapy. While our need to understand the pathogenesis of aspergillosis is high, the
experimental tools for genetics in Afu are limited. Most genetic approaches rely on changing the
level of the gene of interest using disruption or overproduction strategies. Doxycycline-regulated
promoter systems have also been used but these also only indirectly effect the level of the
target protein by altering its mRNA production. Here we describe a new approach to analysis of
the transcriptional control of virulence in Afu by regulated proteolysis of transcription factors
already known to be important in pathogenesis. We have expressed an anti-GFP nanobody
(GFPNb: single chain antibody from camelid species) fused to a mammalian E3 ligase enzyme
(Rnf4) and found this fusion protein to trigger proteolysis of GFP fusion proteins in Afu.
Expression of this fusion protein is under the control of a doxycycline-inducible promoter system
allowing us to trigger protein degradation with the addition of doxycycline. We propose to
accomplish two goals in this application. First, we will prepare GFP fusion proteins to 8 different
transcription factors already known to be required for virulence when deleted from the cell. We
will test all of these fusion proteins for localization, expression, phenotype and the ability to be
degraded by the GFPNb-Rnf4 fusion protein. We will select up to 4 of these fusion proteins to
test in a mouse infection model based on their retention of a normal in vitro phenotype and
sensitivity to the GFPNb-Rnf4-mediated degradation. Immunosuppressed mice will be infected
with these strains and then treated with doxycycline at different times to determine if the acute
proteolytic removal of a factor of interest has an impact on fungal burden/survival. We will also
confirm loss of a given factor after doxycycline treatment by western analysis of proteins from
the mouse lung. This approach of directly degrading a transcription factor of interest, coupled
with the ability to do this in a time-dependent manner, represents a fundamentally different
means of interrogating the progression of mammalian infection by Afu.

Public health relevance
Aspergillus fumigatus is the major human filamentous fungal pathogen, with a mortality approaching 90% during infections caused by drug resistant forms of this fungus. This work will focus on the transcriptional control of virulence in A. fumigatus by using a newly developed system that can trigger proteolysis of selected factors in a time- dependent manner. No technology for selective proteolysis of A. fumigatus proteins is currently available and this application will provide a valuable new experimental tool for study of pathogenesis.